Pre-exposure prophylaxis (PrEP) information on social media

Project Abstract
The continuing HIV epidemic in the U.S. remains a critical health issue for young priority populations bearing a
disproportionate burden of infection. Daily oral PrEP (and as of December 2021, a long-acting injectable
cabotegravir) is safe and effective in reducing the risk of sexual HIV acquisition in adults and adolescents, yet
PrEP awareness/usage remains low. Accordingly, interventions are sorely needed to address PrEP awareness
and mitigate potential barriers related to PrEP use. One such intervention modality is social media (SM), as HIV
knowledge, PrEP awareness, and communicating issues, such as access and cost, are easily addressable via
clear SM messages on platforms young people already use frequently. Given that PrEP awareness/usage
remains low and that SM may be a viable intervention modality for increasing PrEP facilitators and reducing
barriers, the overall objective of this proposed exploratory research project is to 1) characterize the SM landscape
regarding PrEP and HIV prevention messages and 2) develop new and improved behavioral theory-based
messages about PrEP that are clear, specific, consistent, and scientifically up to date. With a robust and
multidisciplinary team across 2 institutions, we will accomplish this objective via 3 SPECIFIC AIMS: AIM 1:
Characterize PrEP-related communications across 3 popular social media platforms (Facebook,
Instagram, and Twitter), identifying message and source characteristics. Using content analytic methods,
we will access, human code, and analyze publicly available PrEP-related SM posts/messages, describing
features of messages, posters/users, and social networks. AIM 2: Build a predictive, explainable health
communication model, guided by the Multilevel Model of Meme Diffusion (M3D), to determine the
diffusion potential of PrEP-related messages. We will apply machine learning methods to characterize PrEP
message features; develop/evaluate a predictive model of a message diffusion potential using large-scale
training data; and apply the model to predict a set of online diffusion metrics for a given message and assess its
ability to reach online PrEP-relevant populations. AIM 3: Develop and pilot test PrEP promotion messages,
for several young priority populations, for implementation/evaluation in a future project. Using human-
centered design (HCD) principles, we will engage 2-3 end-user segments in iterative rounds of SM message
development and testing. This proposed R21 will yield a deeper understanding of PrEP promotion messaging
on SM and produce a “library of messages,” tailored for several young priority populations at risk for HIV. Such
messages will be empirically tested in a future R01 project, and assessed for evidence of behavior change (i.e.,
PrEP usage). Such knowledge may be employed in innovative/targeted efforts via well-liked and accessible
digital tools, such as SM, effectively supporting the updated National HIV/AIDS Strategy for the U.S.

Public health relevance
Project Narrative Interventions, including health communication interventions via social media, are sorely needed to address the lack of pre-exposure prophylaxis (PrEP) awareness and mitigate barriers related to PrEP usage/adherence among young people who bear a disproportionate burden of HIV infection (e.g., young bisexual men, trans women), particularly regarding the potential for social influence, norm setting, and reduction of stigma. This proposed exploratory research project will characterize the social media landscape regarding PrEP and HIV prevention messages and develop new and improved messages about PrEP that are clear, specific, consistent, and scientifically up to date. Together, this knowledge and improved messaging can enhance and target efforts via popular and accessible digital tools and new technologies, such as social media, effectively supporting the updated National HIV/AIDS Strategy for the U.S.